Administration

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
ADMINISTRATION - PROJECT SUMMARY/ABSTRACT
Montefiore Einstein Cancer Center (MECC) Administration provides efficient and innovative centralized
administration, analytics and programmatic infrastructure that enables exceptional basic, translational, clinical
and population-based research at MECC. Administration partners with, and serves, MECC senior leadership to
foster scientific collaboration, implement strategic planning and evaluation efforts, create and disseminate
membership tools and metrics, staff leadership meetings and retreats, coordinate and manage pilot project
competitions, recruit and onboard new investigators, and manage and report on investments and all MECC
accounts, ensuring compliance with all institutional policies and federal requirements. Administration facilitates
rigorous cancer-related research operations and administration, community outreach and engagement,
catchment area research, cancer research training and education, and plans to enhance diversity, to carry out
MECC’s mission to “reduce the burden of cancer in the Bronx and the nation through our cancer-focused
research, education and training, and community outreach and engagement with delivery of compassionate care
for all, including historically underserved communities that face heightened inequities in cancer and social
determinants of health.” MECC Administration staffs all internal and external planning and evaluation efforts,
develops policies and processes to manage membership and all corresponding metrics and tracking, has shared
oversight of shared resources with the Dean’s Office at the Albert Einstein College of Medicine (Einstein),
supports the Director in all faculty recruitment, administers and tracks pilot projects and other internal research
awards, has shared oversight of space and facilities, oversees communications, marketing and the MECC
website, and is staff to Senior Leadership Team and Research Leadership Council meetings and all MECC
scientific retreats. Administration has direct oversight for all MECC budgets and finance, space, facilities and
equipment, human resources, philanthropy, and clinical trials and clinical research operations.
Administration’s success is demonstrated through the extensive work with Senior Leadership to develop and
implement a rigorous planning and evaluation process to support the MECC Strategic Plan 2021-2026, inclusive
of staffing eight Strategic Working Groups with tools to track progress; manage the exceptional institutional
investment to realize goals, support analytics and strategic decision making for the new research program
structure, align and implement new shared resource collaborations, launch a new, integrated website for the
MECC and create a new Membership Dashboard and online administrative tools to manage membership, pilot
projects and CCSG metrics.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward CANCER CENTER ADMINISTRATION - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page